FOXN1 variant regulation of T cell production

Project Summary
The thymic tissue is the only organ supporting the development of the T cells of the immune
system. The quintessential stromal cell type in this tissue needed for thymopoiesis is the thymic
epithelial cell (TEC). TECs govern the positive and negative selection of T cells in the thymus.
The master transcriptional regulator of TECs is the Forkhead Box N1 (FOXN1) gene. Three
distinct autosomal recessive FOXN1 mutations were identified several decades ago, resulting in
a nude and T-B+NK+ severe combined immunodeficiency phenotype. The T cell lymphopenia
resulted from an athymia. In such cases, an allogeneic thymic tissue transplant, depleted of
hematopoietic cells, remains the best clinical strategy for restoring some T cell development.
Recent widespread use of genome sequencing for patients who have low T cell receptor excision
circles (TRECs), which is a measure of low T cell output from the thymus, has increased the
number of human FOXN1 variants to >500. As described in our prior JCI and JACI publications,
we categorized the diverse FOXN1 variants based on their impact on protein function and
thymopoiesis. Interestingly, most patients with low TRECs who had single allelic FOXN1 variants
normalize their peripheral T cell numbers over time. This presents a major conundrum as to how
such patients should be managed clinically. Thus, a serious scientific gap exists in our
understanding as to why most single allelic FOXN1 variants result in a transient T cell
lymphopenia. In this exploratory grant, we will determine if a previously unconsidered mechanism
involving monoallelic FOXN1 expression accounts for the transient T cell lymphopenia. This will
be done with mouse models genocopying selected human FOXN1 variants. Comparing the allelic
expression of Foxn1 in TECs at embryonic, postnatal, and aged stages will establish whether
monoallelic gene expression predominates at specific developmental stages. Since certain
human FOXN1 mutations are more damaging than others, understanding their impact on
thymopoiesis is also needed for appropriate clinical management. Our proposed studies will
include modifications to thymus organoid procedures that enable a comparison of different
epithelial cells for their capacity to support tissue growth. This will include the use TAT-FOXN1
fusion proteins that can be transduced into Foxn1-deficient TECs, prior to reaggregate thymic
organ culture assembly, to compare the different human variants. With our strong expertise in
thymus tissue specification and organ cultures, we will identify novel strategies to improve thymus
functionality.

Public health relevance
Project Narrative The thymus is an organ where the T cells of the immune system develop. Infants born with mutations in a transcription factor called FOXN1 develop smaller, and sometimes undetectable thymuses, although which gene mutations cause these problems remain unclear. We will characterize various human FOXN1 mutations to determine which result in serious thymus problems for patients and whether we can form thymus organs to overcome this defect.